Midwest TXTXT: Scale up of an Evidence-Based Intervention to Promote HIV Medication Adherence

PROJECT SUMMARY ABSTRACT
In this application, we propose to scale up an Evidence-Based Intervention- TXTXT- by creating a regional hub
in the Midwest to coordinate broad dissemination, and to greatly increase reach and impact. We will evaluate
the implementation of the EBI scale up via a hybrid type II design to inform the broad dissemination of a
region-based implementation model and will elaborate a sustainability plan for TXTXT to inform wide scale
dissemination and rapid scale up to additional US regions.
Specific Aims:
1. Determine the real-world efficacy of a regional scale up of an EBI- TXTXT- on our primary and
secondary outcomes: adherence, viral load suppression, and retention in HIV care, respectively, among
poorly adherent racial/ethnic minority YLH, ages 16-35 at 3-and 6-month follow-up.
2. Apply the Consolidated Framework for Implementation Research (CFIR) to describe the implementation
process and identify barriers and facilitators needed to be addressed; and measure implementation
outcomes of the TXTXT intervention using the RE-AIM framework (Reach, Efficacy, Adoption,
Implementation, Maintenance).
Dr. Johnson is an ideal candidate for an HIV-focused Implementation Science mentorship award. She is a
trained Infectious Disease Epidemiologist with initial certification in Implementation Science approaches and
methods (not yet applied). As an early career HIV prevention scientist, she has a breath of experience that
stems from community-engaged research which includes basic science, including surveillance and
epidemiology as well as intervention development and capacity development initiatives. The next logical step is
to gain skills in systems-level implementation science and sustainability planning to inform broad dissemination
of evidence-based interventions. This study combines behavioral and social science, implementation science,
and information dissemination towards the ultimate goal of public health impact. Medication adherence is a key
driver of viral suppression and this regional TXTXT initiative, with a longer-term objective of national
dissemination and focused on patients at most risk of virologic failure will directly address local, regional and
national goals to End the Epidemic by 2030.

Public health relevance
PROJECT NARRATIVE Youth living with HIV, particularly racial/ethnic minority youth, have the lowest rates of viral suppression among people living with HIV, effective interventions exist to support medication adherence and should be scaled up to ensure equitable access. This proposal addresses these gaps and disparities by scaling up TXTXT, a CDC EBI, in the Midwest via a regional hub model with an established AIDS Education and Training Center (AETC), the Midwest AETC (MATEC). By using both a CDC EBI and HRSA AETC, we build on existing infrastructure, to test an implementation approach with potential for nation-wide scale up that will directly address local, regional and national goals to End the Epidemic by 2030.